OTHER FUNCTIONS - EXPLORATORY TOXICOLOGY STUDY IN RATS NSC-XX Orally Task Order 5

Exploratory Toxicology Study in Rats Administered NSC-XX Orally. The test article will be administered daily for 5 days for 2 cycles